Mouse Modeling (MM)

Project Summary/Abstract: Mouse Modeling
Mice are by far the most commonly used vertebrate research model organism for biomedical research, and the
ability to generate efficiently genetically-engineered mouse models (GEMM), maintain those mice, and use
them for sophisticated experimentation is the basis for the dominance of mice for mammalian biomedical
research. As with most biomedical research platforms, the utilization of mice is complex, and often researchers
need specialized support to accomplish their mouse experiments. The Mouse Modeling (MM) Shared
Resource is focused on supporting researchers doing mouse experimentation by offering a broad range of
services that are adapted for specific experimental needs, updating services with the latest technological
approaches and doing this service in an efficient and cost-effective manner. By keeping the focus on flexibility,
cutting-edge capability and efficiency of services, we have been able to support mouse model experimentation
by many researchers and remain financially solvent for over 21 years. The vast majority of the experiments we
support are cancer-focused, with other major areas including neuroscience, infectious disease and antibody
generation. During the current award period services were performed for 27 Cancer Center Members, 25 of
whom now are Members of all 4 NCCC Programs (CPS [1], CBT [11], ICI [10], and TEC [3]). NCCC Funded
Members represented 37% of Total MM projects served (549), and we are requesting only 24% of the Total
MM Operating Budget from CCSG support. As an example of value added to NCCC research, “Floxed” ID2
mice were generated by the MM Shared Resource for a study investigating the role of ID2 in glioma biology,
and now these mice are available for other researchers, here and outside Dartmouth, and can be combined
with Cre-expressing mice to study the biology of ID2, a gene that that plays a role in multiple different cancers.
In a second study involving genetically engineered mice, including a knock-in of a Cre-expression-regulated
allele of constitutively active P110 of P13 kinase, the resulting model was the first reported rapidly developing
murine breast tumor model that generates predominantly adenocarcinoma breast tumors, pathologically similar
to human breast cancer. In contrast, other models are either very slow to develop or generate sarcomatoid
breast tumors, which are rare in human breast cancer. MM’s menu of services constantly is evolving to
respond to changing technologies and changing needs of new and established faculty at Dartmouth. Recently,
we have been more involved providing mouse model experimentation services to support labs that either are
not experienced with mouse experimentation or do not have sufficient lab personnel to support needed mouse
studies, such as engineering faculty from Dartmouth’s Thayer School of Engineering, or research clinical
faculty from Dartmouth-Hitchcock. Another new area of focus for MM is the use of CRISPR/Cas9 to make
directly targeted genetic modifications in mouse zygotes with no intermediate tissue culture step with ES cells.
Multiple mouse models have been made, and we continue to develop skills with this powerful technology.